HIGH RESOLUTION MICROSCOPIC MRI OF EXCISED HUMAN CENTRAL NERVOUS SYSTEM TISSUE

MRI microscopy of fixed human brainstems have revealed surprising amounts of detail of use in anatomical studies of normal and damaged brains.